Structural and biochemical investigations into the mechanism and evolution of soluble guanylate cyclase regulation

Project summary
Nitric oxide (NO) is an intercellular signaling molecule used across several kingdoms of life, and in animals,
NO is involved in key processes like vasodilation, neurotransmission, and the host response to infection. Central
to NO function in animal physiology is the metalloenzyme soluble guanylate cyclase (sGC), which generates the
secondary messenger guanosine 3’,5’-monophosphate (cGMP) in response to NO1,2. Because of its centrality
to several physiological processes in humans, sGC is a current therapeutic target3, and understanding the struc-
tural underpinnings of sGC activation will inform continued development. Though NO has only been proven to
bind at the heme cofactor, sGC activity has three distinct stages: 1) low basal activity without NO bound (NO-
free), 2) moderate activity (10-fold increase) with a single, heme-bound NO (1-NO), and 3) maximal activity (200-
fold increase) with excess NO4. Biochemical5 and structural6,7 experiments suggest NO allosterically regulates
sGC activation through elongation of a coiled-coil domain between the N-terminal NO-binding regulatory domain
and the C-terminal catalytic domain. However, interdomain arrangement and the conformational population dis-
tribution of the physiologically relevant 1-NO state remain to be fully explored. While metazoan sGCs exist as
heterodimers with only one heme-binding domain, the recently discovered single-celled eukaryotic Choanoeca
flexa (Cf) sGC is a homodimer that nonetheless exhibits half-sites heme-loading and 3-stage NO-activation8,9.
Through this proposed research, we will probe how Cf sGC allosterically modulates activity in response to NO
stimulation. Activity assays, homology-guided mutational studies, and a survey of small molecule stimulators will
be used to characterize Cf sGC activation. Cryo-electron microscopy will be used to determine high-resolution
structures of Cf sGC in active and inactive states, allowing for visualization of key structural similarities and
differences between Cf sGC and animal counterparts. Small-angle X-ray scattering (SAXS) experiments will be
performed with both Cf sGC and animal sGCs to deconvolve the putative 3-stage NO-activation profile of sGC.
These experiments aim to identify and describe the structural states of Cf sGC and illuminate the structural
differences between ancestral and animal sGCs that define the evolutionary history of NO-based signaling.

Public health relevance
Project narrative Soluble guanylate cyclase (sGC) is an enzyme central to the nitric oxide (NO) signaling pathway in animals. However, a complete structural and mechanistic understanding of the 3-stage activation of sGC by NO has thus far remained elusive. This proposal will harness a newly discovered NO-specific sGC from the colonial single- cell choanoflagellate, Choanoeca flexa, to explore the structural and evolutionary trajectory of sGC regulation using mutagenesis, cryo-electron microscopy, and small-angle X-ray scattering.